Mentoring Patient Oriented Research in Allergic Eosinophilic Gastrointestinal Disorders

Project Summary
EoE is a newly recognized chronic, antigen driven allergic disease that causes tissue remodeling. Esophageal
remodeling includes fibrosis and smooth muscle hypertrophy/dysfunction that leads to esophageal rigidity and
dysmotility. Clinical symptoms include vomiting, poor growth, dysphagia, food impactions, and strictures. My
patient oriented research (POR) program focuses on elucidating the mechanisms and clinical impacts of
esophageal remodeling in children. Herein I propose to become an outstanding POR mentor to a diverse group
of undergraduate/graduate students, postdoctoral fellows, and junior faculty trainees from multiple disciplines
and to continue and extend my research to understanding EoE as a disease of both inflammation and
“mechanotransduction”. In the Research Plan, I test 3 hypotheses on the fundamental mechanisms of EoE. The
first is a potentially paradigm shifting central hypothesis that a rigid matrix alters the function of esophageal
fibroblasts and smooth muscle cells to propagate EoE together with, and independently of, inflammation. This
has the clinical implication that there is a pressing, unmet clinical need for therapies that target inflammation-
independent remodeling. The second hypothesis, an extension of my current POR, is that the adherens junction
protein, E-cadherin, is pivotal in the loss of esophageal epithelial cell barrier function and that super resolution
microscopy is a cutting-edge tool that will aid our understanding of the interaction between barrier function and
E-cadherin localization at the nanometer level. The third aim is to evaluate gender differences in EoE severity
with the hypothesis that male fibroblasts are intrinsically more biased to esophageal inflammation and
remodeling. Together with my collaborators and our co-mentees, I have developed and utilized innovative
primary human models that transition from single cells and intact multicellular and functional ex vivo human
mucosal platforms to an in vivo analyses of esophageal rigidity and motility in children. With our large, well-
phenotyped EoE population, we are able to continuously translate our findings back to the patient. I have involved
mentees in each of my aims, developed a formal plan to train junior investigators in the lab, clinic and career
path, created a formal mentoring plan and team for my mentees and myself, and integrated the unique resources
at UCSD including the CTSA funded Clinical and Translational Research Institute. I have a strong record of
funded POR and training mentees but require the protected time and further education to become the inspiring
mentor I envision. This is an important goal for sustaining research and creating a legacy of investigators in
eosinophilic gastrointestinal disorders (EGIDs). My past and current group of mentees are from
Allergy/Immunology, Gastroenterology, and Bioengineering, all of whom are dedicated to, and united by, the
singular goal of unraveling mechanisms of EGIDs and bringing the findings back to the patient. The combination
of a multidisciplinary mentee team, an outstanding research and institutional environment, and a strong
mentoring plan are key to the success of this proposal.

Public health relevance
Project Narrative EoE is an allergic disease of increasing prevalence that requires repeated esophageal biopsy and is treated with anti-inflammatory therapy to control the complications of esophageal rigidity, strictures, and food impactions caused by fibrosis and smooth muscle changes referred to as tissue remodeling. I have a strong foundation of mentoring trainees and conducting patient oriented research (POR). I proposes to integrate funded research and strong pool of junior investigators from multiple disciplines to become an outstanding POR mentor and expand my current EoE remodeling research to unanswered questions of how a rigid matrix alters structural cell function, gender differences, and mechanisms of epithelial barrier dysfunction in EoE.